A Transdisciplinary Approach to Investigating Metabolic Dysregulation in Obese Parent and Child Dyads and Risk of Colorectal Cancer - admin supplement

PROJECT SUMMARY
Obesity increases the risk for colorectal cancer (CRC). Indeed, epidemiological studies have found a strong link
between a poor diet and colorectal cancer and experimental studies in mice substantiate these claims. Because
adiposity and diet drive metabolic dysregulation, we posit that understanding the interaction between diet and
adiposity are key to understanding the genesis of CRC (as well as other obesity-related cancers). The
insulin/insulin-like growth factor (IGF) system, which is dysregulated in obesity and functions on a pro-
inflammatory substrate, is a major determinant in the pathogenesis and progression of CRC. Low-grade, chronic
systemic inflammation (i.e., meta-inflammation) associated with obesity – is inextricably linked to these metabolic
derangements. Indeed, inflammatory mediators contribute to metabolic dysfunction, including increases in
circulating cytokines, decreases in protective factors like adiponectin, and communication between inflammatory
and metabolic cells. Consumption of pro-inflammatory, energy-dense, often high-fat diets modulate microbiota
and induce alterations in intestinal barrier function that is associated with an increase in low-grade inflammation
and insulin resistance. Thus, gut microbes are likely at the epicenter of the obesity-meta-inflammation-CRC link.
Diet is the most influential factor on gut microbe composition and function and therefore presents a strategy for
intervention including natural products as dietary supplements. Cannabinoids have received recent attention for
their potential health benefits. In fact, the NCI is supporting research on the potential for cannabinoids in cancer
related outcomes. Excitingly, preliminary data that we have collected shows that cannabis administered to obese
mice improves the homeostasis model of risk assessment-insulin resistance (HOMA-IR) and reduces adipose
tissue inflammation and pro-inflammatory macrophages without changes in body weight. These outcomes have
been associated with CRC progression and have been linked to changes to the gut microbiome. As such, this
Diversity Supplement will test the hypothesis that the cannabis plant can reduce meta-inflammation and
subsequent metabolic dysfunction in obesity-associated CRC, and this will be mediated via its actions on gut
microbes. Under this award Christian will 1) achieve training in cutting edge techniques related to metabolic
dysregulation and cancer risk including extensive training in mouse models of cancer, in immune profiling, and
in assessing microbiome and metabolite signatures, as well as in professional development training; 2) publish
1 first author paper and 2 co-author papers for each year of the award; 3) achieve training in career development;
and 4) contribute to the MeDOC consortium. Funding from this Diversity Supplement, mentoring from Dr. Murphy
and support from the other REMEDY investigators (advisory committee: Drs. Hebert, Hofseth, Velazquez,
Kubinak, and Li), the MeDOC consortium, and the resources at the University of South Carolina will allow
Christian to achieve his goal of becoming an independent investigator focused on metabolic dysregulation and
cancer risk.

Public health relevance
PROJECT NARRATIVE Epidemiological studies have found a strong link between obesity and colorectal cancer and experimental studies in mice substantiate these claims. Based on our convincing preliminary data that shows that the cannabis plant can reduce inflammation and metabolic dysregulation – factors that are associated with driving tumorigenesis - we will test the hypothesis that the cannabis plant can reduce meta-inflammation and subsequent metabolic dysfunction in obesity-associated colorectal cancer. This work will provide Chrisitan with extensive training in mouse models of cancer, in immune profiling, and in assessing microbiome and metabolite signatures, as well as career development that will provide a platform for Christian to launch his independent career focused on metabolic dysregulation and cancer risk.